Surfactant Protein C Mutations and Interstitial Lung Disease

Idiopathic pulmonary fibrosis (IPF) a progressive scarring interstitial lung disease (ILD) that affects mainly older
adults remains a significant unmet therapeutic need. The recent paradigm shift wherein the concepts of repetitive
injury to a dysfunctional, vulnerable, alveolar epithelium coupled with an abnormal wound healing response serve
as disease “drivers” is opening up new opportunities for therapeutic discovery in IPF. Over 60 mutations in the
alveolar type 2 cell (AT2) restricted, Surfactant Protein C [SP-C] gene [SFTPC], have been found in sporadic
and familial IPF and provide important clues for understanding IPF pathogenesis. Since its initial funding over
10 years ago, this Merit Review program has addressed the unmet need for veterans with IPF by leveraging two
novel knock-in mouse models of spontaneous lung fibrosis which express clinical SP-C mutants in alveolar type
3 (AT2) epithelial cells in an inducible fashion to study IPF. The latest renewal (2021) received a 3%ile score
and was awarded 8 years of funding as a Senior Clinician Scientist Investigator Award through 2029. This project
is designed to interogate cell quality control and integrated stress responses to define key alveolar niche cell
populations emerging during fibrogenesis and then assess the roles of endogenous endoplasmic reticulum (ER)
stress and AT2 metabolic reprogramming in aberrant injury/repair pathways found in IPF. Using this successful
and stable infrastructure, this supplement is responsive to VA RFA RD-22-029 in that its design will extend the
scope of the parent Merit Review as well as promote diversity through support of the career development of an
outstanding early stage investigator from an under-represented minority (Luis Rodriguez, PhD). The specific
aims are designed to test the hypothesis that defects to cell quality control (macroautophagy; proteasome)
disrupt AT2 metabolism and synergize with aging to disrupt AT2 progenitor function and accelerate senescence
resulting in emergence of a pro-fibrotic niche in the distal lung. Scientific and technical feasibility is supported by
the new preliminary data collected by Dr. Rodriguez that show: (i) Aged mice expressing mutant SPC have
increased mortality as compared to younger mice (ii) AT2 cells in aged mice present with increased markers of
cellular senescence (iii) Aged mice have an increased prevalence of AT2 transitional cells and (iv) AT2
transitional cells demonstrate increased metabolic dysfunction. The contemplated experimental approach will
characterize synergism between multiple disrupted pathways associated with pulmonary fibrosis. In Aim 1 a
doxycycline inducible SftpcI73T murine epithelial cell line will be used to evaluate the impact of senescence on
AT2 cellular metabolism. Aim 2 leverages the availability of aged (>18-month-old) SftpcI73T IPF mice to
determine the impact of aging and AT2 metabolic reprogramming on senescence and progenitor function (and
vice versa). Our approach uses both reductionist and integrative models and offers the unique opportunity to
comprehensively identify mechanisms and pathways promoting crosstalk between AT2 cells, inflammatory cells
and fibroblasts that drive parenchymal remodeling. While the results achieved in this supplement will provide
significant scientific impact to the field of IPF, of equal value will be its contribution towards achieving the
objective of advancing diversity in the VA biomedical research workforce by providing critical infrastructure,
data, and mentoring to support the next steps in career development of the proposed mentee punctuated by
successful competition for a VA CDA.

Public health relevance
Idiopathic Pulmonary Fibrosis (IPF) is a devastating lung disease of older adults marked by progressive respiratory failure for which there remains a significant unmet need for effective medical therapies. The proposed project represents a supplement to a funded VA Merit Review that studies the pathophysiologic origins of epithelial dysfunction in IPF using novel mouse models of spontaneous lung fibrosis. The proposed supplement focuses on the role of age dependent aberrant cell quality control and metabolic reprogramming in the disruption of lung progenitor cell function and promotion of cell senescence as drivers of IPF. Results funded by this supplement will extend the scope of the parent Merit Review as well as support the career development of an outstanding early stage investigator from an under-represented minority by providing critical infrastructure, data, and mentoring to support next steps in career development including a VA CDA funding mechanism.